Mucociliary innate defense mechanism in the human distal airway

Mucociliary Innate Defense Mechanism in the Human Distal Airway
Project summary
Airway mucociliary clearance (MCC) is a critical innate defense system for maintenance of lung health. Failed
mucus transport is common to the pathogenesis of muco-obstructive lung diseases (MOLDs). Mucociliary
transport (MCT) rates, governed by cilial and mucus properties, are reportedly slower in vivo in distal airways,
reflecting in part shorter cilia and reduced ciliary cell density. Mucus concentration is another key parameter that
determines MCT. However, mechanisms that integrate regional cilial and mucus properties into MCT are not
understood. This question is particularly important in small airways (< 2 mm in diameter), as they are the earliest
and most affected region in MOLDs. Our prior studies have demonstrated reduced mucin secretion with robust
CFTR-mediated fluid secretion in small airways, both activities dominated by secretory club cells, suggesting
that mucus is less concentrated in the small airways relative to proximal airways in health. Basic physiology
questions include: 1) why do small airways exhibit slower MCT; 2) how is slower MCT produced by integrated
small airway epithelial cellular activities; and 3) what is the cost for the slower MCT with less concentrated mucus
to the small airway region? Answers to these questions likely relate in part to the exponential decrease in surface
area from distal to proximal airways. Accordingly, we hypothesize that mucus production and clearance in
small airways is tightly regulated to achieve a balance between airway protection and efficient
intraregional mucus clearance. Small airway epithelia produce a relatively dilute mucus that is
transported at relatively slow rates to prevent accumulation in central airways. While this property is
necessary to accommodate decrease in surface area from distal to proximal airways, the dilute mucus
layer and slower clearance rates also lead to increased vulnerability to inhaled toxicants in small airway
regions. To test this central hypothesis, we propose the following aims: 1) Identify region- and cell type-
specific regulatory mechanisms for the MCT in human airways. We will identify region-specific MCC
regulatory mechanisms, utilizing human large and small airway cell and tissue explant culture models. We will
then relate region-specific MCC functions to epigenetic regulatory elements determining region-specific airway
epithelial cell types, utilizing multi-omics approaches. 2) Identify pathways determining the distal airway
secretory club cell as a multi-dimensional ion/mucin regulatory cell that controls small airway mucus
properties. 3) Identify mechanisms that produce failure of mucociliary innate defense systems in the
distal airway in MOLDs. We will test whether failure of the transcriptional regulation required to maintain distal
airway specificity causes local MCC dysfunction in small airway epithelia. Our overarching goal is to generate
mechanistic insights into region-specific mucociliary innate defense mechanisms with a focus on small
airways. Achievement of our goal should provide a new paradigm to understand MCC in the normal lung and
how to approach novel therapies for MOLDs.

Public health relevance
Mucociliary Innate Defense Mechanism in the Human Distal Airway Project narrative Airway mucociliary clearance is a regionally coordinated critical innate defense system for maintenance of lung health, with failure of this system being a common feature of muco-obstructive lung diseases. Our overarching goal is to gain mechanistic insights into region-specific mucociliary innate defense mechanisms with a focus on small airways that are characterized as the earliest, most affected region in muco-obstructive lung diseases. Achievement of our goal should provide a new paradigm in our understanding of mucociliary clearance system in the lung and how to approach novel therapies for muco-obstructive lung diseases. 1